Dissecting neural-immune mechanisms of psychosis and related neurodevelopmental disorders

Project Summary/Abstract
Altered neural-immune (NI) gene expression has been observed in postmortem brain tissue from individuals with
schizophrenia and other neurodevelopmental disorders. One mechanism by which NI function may affect the
brain is through effects on neurite outgrowth and synaptic pruning during development; however, the effects of
NI gene expression on in vivo brain development and behavior are not known. A major barrier to understanding
how interindividual differences in NI expression relate to heterogeneous developmental trajectories is the inability
to measure gene expression in the living human brain. Through a coordinated set of multimodal analyses, the
current proposal aims to define the polygenic architecture of NI gene expression to generate a genome-wide
resource for individual-level prediction and characterization of its impact on brain and behavioral trajectories in
the pediatric population. Integrating functional genomic data from the PsychENCODE Consortium with several
other large-scale resources, we will perform a multi-ancestry genome wide association study (GWAS) to identify
the genetically regulated component of NI expression (GREx) in >4,000 human brain samples (Aim 1). Next,
using genetics data in >11,000 multiethnic youth from the Adolescent Brain Cognitive Development (ABCD)
Study, we will compute individual-level predictions of NI GREx and test the relationship with longitudinal
trajectories of structural brain development (Aim 2). Finally, to examine how interindividual variability in NI GREx
may relate to clinically-relevant symptomatology, we will test the relationship between NI GREx and age-related
change in dimensional measures of mental health relevant to psychosis and other related neurodevelopmental
disorders (Aim 3). By examining links between NI GREx and brain development in a large population-
representative cohort of children, this project has the potential to inform our understanding of mental health as a
continuous construct, and to aid in the prospective identification of individuals at heightened risk for psychosis
and other psychiatric disorders. These aims are in-line with the NIMH strategic plan to define the brain
mechanisms underlying complex behaviors, and to examine mental illness trajectories across the lifespan. The
proposed research will take place at the University of California, Los Angeles (UCLA) under the mentorship of
Drs. Daniel Geschwind, Carrie Bearden, Bodgan Pasaniuc, and Wesley Thompson, experts in functional
genomics, psychosis spectrum disorders, computational genetics, and longitudinal statistical analyses,
respectively. The proposed K01 will provide the PI with mentored research training in transcriptomics, including
the analysis and interpretation of post-mortem human brain RNA-sequencing data, multi-ancestry GWAS, the
neurobiology of psychosis, and statistical methods to model longitudinal data. This research and training will lay
the foundation for the PI’s career development as a leading expert in the neurogenetic etiology of psychosis and
pleiotropic psychiatric disorders. Results will support a future R01 extending this work into clinically ascertained
populations and will elucidate the genetic mechanisms underlying neurodevelopmental heterogeneity in youth.

Public health relevance
Project Narrative Neural-immune pathways play a critical role in neurodevelopmental processes and growing evidence suggests that neural-immune gene expression is dysregulated in schizophrenia and other neurodevelopmental, psychiatric disorders. This project will (a) integrate gene expression and genotype data to generate a genome- wide resource for individual-level prediction of neural-immune gene expression, and (b) characterize the impact of genetically predicted neural-immune gene expression on longitudinal trajectories of structural brain development and change in dimensional measures of mental health relevant to psychosis in children and adolescents. Results will significantly expand our understanding of the genetic mechanisms regulating gene expression in the human brain and the developmental etiology of mental illness, thereby informing the development of targeted biologically-based treatments to reduce the burden of disease.